INFORMATION TECHNOLOGY 2009

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The IT Department provides local and wide area network connectivity, file and print services, database administration, information security support, Internet and Intranet web site development and maintenance, application development, training and end-user assistance to approximately 200 Center staff. AIDS related.